ROLE OF BRONCHIAL CIRCULATION IN ACUTE AIRWAY OBSTRUCTION

This study is designed to explore the role of bronchial circulation in acute airway obstruction by 1) manipulating bronchial blood flow and vascular engorgement, and 2) by comparing intra-airway temperatures before and after antigen exposure.